The Effect of Light Intervention on Recovery in Individuals with Opioid Use Disorder (OUD)

PROJECT SUMMARY/ABSTRACT
In opioid use disorder (OUD), sleep and circadian disruptions are highly prevalent, interfere with opioid mainte-
nance treatment (OMT) outcomes and increase the risk of relapse. So far, the neurobiological mechanisms
linking sleep/circadian disruptions and relapse remain unclear and commonly used pharmacological sleep treat-
ments fail to improve sleep or decrease illicit drug use in OUD. Thus, there is an urgent need to fill this research
gap.
The overall objective for this proposal is to determine 1) (Aim1/K99) whether dopaminergic dysfunction underlies
sleep and circadian disruptions in OUD and 2) (Aim2/R00) whether bright light therapy can reduce sleep and
circadian disturbances, normalize dopaminergic transmission, and improve treatment outcomes in OUD. The
primary hypotheses are that altered dopaminergic transmission in OUD plays an essential role in observed
sleep/circadian disruptions in OUD. While greater sleep disturbances are expected to correlate with lower D2R
availability, delayed circadian rhythms are expected to correlate with greater D1R availability. Daily exposure to
bright light in the morning is expected to advance circadian rhythms, improve sleep, normalize the D1R:D2R
ratio and facilitate recovery processes in OMT OUD patients. To test the hypotheses, a multi-method approach
including actigraphy, polysomnography, salivary melatonin and questionnaires will be used to assess sleep and
circadian rhythms and PET scans will be performed to assess striatal D1R and D2R availability. A randomized,
placebo-controlled trial will be conducted to assess the effect of a home-based bright light therapy on OUD
recovery. OUD patients (on OMT >1 month) will be assigned either to bright white light (10000 lux) or to dim-red
light placebo (<300 lux) group for 2 weeks. Their sleep, circadian rhythms and dopamine receptor availability will
be measured before and after treatment.
My long-term goal is to become an independent investigator studying brain mechanisms linking sleep/circadian
disturbances and drug use, and thereby facilitating the development of effective sleep and circadian interventions
for patients with substance use disorders. To achieve my goal, I propose trainings that will help me 1) gain clinical
experiences in addiction research, 2) expand my research toolbox with PET, which will allow me to examine
brain correlates at molecular level, 3) expand my expertise and tools in clinical sleep research and interventions
and 4) enhance my professional skills critical for an independent research career. I will acquire these knowledge
and skills under the guidance of a group of leading experts in the field of addiction, sleep and PET imaging,
including my mentors (Dr. Nora Volkow, Dr. Martica Hall and Dr. Richard Carson) and my internal and external
consultants (Dr. Dardo Tomasi, Dr. Dante Picchioni, Dr. Christopher Welsh, Dr. Brant Hasler). Additionally, NIH
offer me plentiful resources for successfully completing proposed research project and training plans. The pro-
posed research and trainings will prepare me well for an independent tenure-track position.

Public health relevance
PROJECT NARRATIVE Opioid use disorder (OUD) is a chronic relapsing disorder and is well-known for its high-risk rate of overdoses and death. Sleep and circadian disruptions are highly prevalent in OUD and increase the risk of relapse. The proposed observational and interventional study will advance OUD treatment by identifying neurobiological mechanisms underlying sleep and circadian disturbances and by generating fundamental scientific and therapeutic knowledge on the potential effects of bright light intervention on sleep, circadian rhythms, dopaminergic system and recovery in OUD.